A novel population of PLZF+CD8+ regulatory T cells: phenotype and function

Immune tolerance mediated by regulatory T cells (Treg) is important in the control of inflammatory and autoimmune diseases. The detailed biology of CD8 Treg is lacking due to the absence of molecular markers to distinguish them from conventional CD8+ T cells (CD8conv), as Foxp3 expression is for CD4 Treg. We have discovered that the expression of the promyelocytic leukemia zinc finger (PLZF) transcription factor together with other markers distinguishes a novel, unconventional CD8 Treg population from other CD8conv as well as unconventional T cells. Though, CD8 Treg are enriched in liver of naïve mice, they are also present in other lymphoid tissues and in human PBMC and display an activated/memory phenotype and attributes of innate-like T cells. Our long-term goal is to characterize the biology of CD8 Treg in both mice and humans and to understand the negative feedback regulatory mechanism(s) employed by CD8 Treg that limits excessive immune stimulation. These studies are highly significant as they will have potential to not only uncover a key CD8 Treg-mediated molecular mechanism(s) involved in immune homeostasis, but also will have major implications for the development of new immune therapies in autoimmune diseases. The objective of this grant is to characterize the transcriptome signature, development, activation/expansion and mechanism of regulation of CD8 Treg in murine models and also to determine their molecular and suppressive functions in humans. The central hypothesis is that the PLZF transcription program allows acquisition of innate-like and memory features in CD8 Treg that enables them to control promptly and effectively inflammatory autoimmune responses by targeting activated T cells as well as APCs. Based upon our critical preliminary data that indicate a unique phenotype of CD8 Treg (PLZF+TCR??+CD8??+), we propose the following specific aims: Aim 1. To determine their unique transcriptional program and molecular pathways, single cell RNA sequencing analysis of CD8 Treg subsets will be carried out in both the periphery and in the inflamed CNS. A bone marrow chimeric approach will be used to determine the role of PLZF transcription factor in their development and function; Aim 2. To determine the critical role of the cross-presentation mechanism in the physiological induction of CD8 Treg, mice genetically lacking cDC1 will be used. Genetic depletion of CD8 Treg in PLZFF/F mice will decipher their role in the recovery and resistance from experimental autoimmune encephalomyelitis. A critical role for the regulatory molecules, including CD200 and Fgl2, in the inhibition of DC function and/or Th1/Th17 induction will be elucidated; and Aim 3. To characterize the transcriptional signature and suppressive mechanism(s) involved in human CD8 Treg, sorted cells from peripheral blood of healthy individuals will be used. Collectively, our proposed studies will have a major impact in the emerging field of unconventional T cells and in the CD8 Treg-mediated regulatory mechanism(s) involved in the maintenance of immune tolerance.

Public health relevance
Project Narrative We have discovered a novel population of white blood lymphocytes that are crucial for the maintenance of immune homeostasis that protects us from tissue damage following overstimulation of autoreactive lymphocytes in autoimmune disease conditions. This proposal seeks to characterize these regulatory T cells in both mice and in humans and understand the mechanism by which these lymphocytes are able to control other immune cells from causing tissue injury. This research will have major implications in understanding this novel mechanism of tolerance but also potentially help with the design of novel therapeutic for the treatment of autoimmune diseases, such as lupus, arthritis and type 1 diabetes.